Admin Core

Administrative Core Project Summary/Abstract
We seek to advance NIAID’s mission and address national needs by implementing a
Genomic Center for Infectious Diseases that will utilize a variety of cutting-edge genomic
technologies, including laboratory based methods, bioinformatics processes and
computational analyses to combat infectious diseases. To ensure we carry out this work
efficiently, and with maximum benefit for the wider research community, we have
created an Administrative Core that will be responsible for managing the center. The
Administrative Core features an outstanding leadership team with a long history of
working effectively together. They will apply management practices from industry in
support of complex, collaborative projects that advance high impact research as well as
create and share valuable resources for the wider community, including genomic data,
pipelines and analysis tools. The Admin Core will manage our Center’s priorities,
timelines and milestones, and ensure rapid public data release and dissemination of
resources. To support the highly collaborative nature of our work, the Admin Core will
also manage our interactions with collaborating researchers, NIAID program staff, the
GCID Steering Committee, and other NIAID funded Centers to ensure tight coordination
and cooperation. This will include working with scientists and technology experts at
Broad and other GCIDs to develop novel and innovative pilot projects and creating and
overseeing Scientific Working Groups to advance the shared interests of the centers and
NIAID’s mission. To support other infectious disease researchers’ use of methods,
approaches and resources we generate, the Administrative Core will oversee outreach
and educational activities, including specialized workshops, hosting extended visits from
collaborators, and supporting infectious disease training experiences for undergraduates
from historically underrepresented groups. By establishing and monitoring the proper
metrics for all aspects of our performance, and constantly working to improve our
Center’s processes and scientific questions, the Administrative Core will accelerate
efforts to understand and define the factors that shape host-pathogen and vector-pathogen interactions, the functional consequences of those interactions and our ability
to harness this knowledge to fight infectious diseases.